Non-invasive stimulation for improving motor function in spinal cord injury

DESCRIPTION (provided by applicant): Neuromodulation using non-invasive stimulation techniques in humans is one of the most promising advances in treatment of neurological damage. While extensive work has been done in developing these techniques for therapy targeting the brain, there has been little emphasis on targeting spinal cord directly. We recently a developed a human repetitive stimulation paradigm to target spinal cord that is safe, effective, well tolerated, and results in lasting spinal excitability enhancement. In a small pilot study we showed that this spinal excitability modulation could be replicated in affected lower limb muscles of chronic spinal cord injury patients. Objective: In the present study we aim to: (1) determine if spinal excitability is raised following spinal associative stimulation (SAS) in a larger sample of SCI patients with lower limb paralysis, (2) examine the time-course of after effects, and (3) establish the functional consequences by measuring the change in voluntary motor activation associated with raised spinal excitability, assessed by the presence of background EMG during attempted muscle contraction. Methods: Since our prior work showed that the excitability modulation is contingent upon the paired technique, and not placebo or peripheral stimulation alone, we will provide the real stimulation paradigm in 30 chronic incomplete SCI patients, using a within subjects, pre-post intervention design. The principal outcome measure will be H-reflex threshold as per our previous work in healthy subjects. We will secondarily examine how the effect changes over time by repeating the baseline measures at 0, 15 and 30 minutes post intervention. We additionally be recording surface EMG during attempted maximal voluntary contractions at each of the time points. We expect that spinal excitability will be raised for at least 15 minutes post intervention, and that voluntary activation may be enhanced in association with heightened excitability. Results/Conclusions: If, as predicted, we establish conclusively that our method termed spinal associative stimulation is effective in SCI patients, this could profoundly influence the field of non-invasive stimulation, and open up the potential for a range of techniques for spinal cord targeting, including down-regulating excitability in the presence of spasticity. Significance: Spinal associative stimulation is the first paired non-invasive technique based on known timing-dependent interactions in spinal networks, to modulate spinal excitability. Further, it is one few techniques in humans, ever developed targeting spinal cord, including invasive stimulation.

Public health relevance
PUBLIC HEALTH RELEVANCE: We have shown for the first time a robust method of modulating spinal excitability in a manner resembling spike-timing dependent plasticity. The significance is that residual corticospinal tract fibers, present even in many of the most severely affected SCI patients, are likely to engage more responsive spinal networks after spinal associative stimulation (SAS), and thus increase voluntary activation of weakened muscles. The combination of neuromodulation protocols (aiming to induce plastic changes at the spinal level) and behavioral training (aiming to promote activity dependent plasticity) may be the future of spinal cord rehabilitation. __SpecificAimsTextDelimiter__ SPECIFIC AIMS One of the most compelling advances in treatment for patients with neurological disorders has been the ability to non-invasively modulate brain excitability and improve function. However, until recently there have been no equivalent protocols targeting the spinal level despite the importance of spinal networks in the execution and regulation of motor function. The first non-invasive stimulation protocol to target the spinal level was recently described by our group (Cortes et al, 2011). A sub-threshold Transcranial Magnetic Stimulus (TMS) over leg motor cortex will condition a spinal H-reflex from posterior tibial nerve stimulation, and increase amplitude up to three-fold. We showed that by repeatedly delivering these stimulus pairs, the conditioned H-reflex progressively increases by 25% at the end of 15 min of stimulation and this increase persists after the stimulation ceases. We concluded that the repetitive conditioning paradigm induces short-term plastic changes in the excitability at spinal cord level, and used the term spinal associative stimulation (SAS) to reflect the timed association between activity in the afferent fibers of the posterior tibial nerve (TN) that produce the H- reflex, and efferent activity in the corticospinal tract stimulated by TMS. The significance of SAS-related changes in spinal excitability is that similar changes have been implicated in long-term adaptation during the acquisition of new motor skills (Thompson et al., 2009), and restoration of motor function in animal models with partial spinal cord injury (Chen et al., 2006b). We have tested our paradigm in a small group of people with chronic spinal cord injury (SCI) and found that SAS is also effective. The rationale for applying the SAS protocol is that in muscles with some spared function following spinal cord injury, weak descending activity arriving at the motoneuron pool during voluntary contraction might be more effective if spinal excitability is raised. Our hypothesis is that spinal excitability will be raised following SAS in chronic traumatic incomplete SCI patients and that this will be associated with improved motor performance. Aim 1: To determine if spinal excitability can be raised by SAS in people with chronic incomplete spinal cord injury. Using a within subjects pre-post intervention design, we will test the effect of SAS in 30 chronic incomplete SCI patients with residual lower limb motor function, using our previously published method. The paired stimulation at 20ms interval, will be repeated at 0.1Hz for 15 minutes (90 stimuli pairs). Baseline measures of H-reflex and M-wave Recruitment Curves (RC), will be recorded using surface electromyography over the soleus muscle, immediately prior to the intervention, then immediately post intervention. To establish the time-course of post intervention spinal excitability recovery, the baseline measures will be further repeated at 15 and 30 minutes post intervention. Although our previous work shows that increased spinal excitability following SAS is due to repeated pairing of precisely timed stimuli and not placebo or effects of unpaired stimuli, we will include a control intervention (paired stimulation at 0ms) to account for potential placebo effects in SCI patients. Aim 2: To examine if SAS-induced changes in spinal excitability are correlated with clinical state and voluntary motor function. We will determine what factors might be related to the efficacy of SAS by comparing the magnitude of SAS- induced changes in spinal excitability with baseline measures of residual motor and sensory function, time since injury and the level of injury, and motor and sensory conduction times. Functional consequences of SAS will be determined by measuring maximum force of plantar flexion with quantitative myometry and surface EMG. To quantitatively probe functional connections we will record MEP amplitude with single pulse TMS at rest and during maximal voluntary contraction. The study will establish if SAS is effective in spinal cord injured patients, and the functional and clinical correlates of this form of neuromodulation. The findings are expected to identify those people with SCI who may benefit from this technique, and to pave the way for the combination of physical therapy and SAS in the rehabilitation of people with SCI.